Data Analysis Tools for Emerging High-throughput Technologies

Project Summary
Biomedical research and basic sciences are increasingly dependent on high-throughput technologies capable of
simultaneously measuring thousands of nucleic acid molecules within a sample. As the use of these methods
increases, the resulting complex datasets require the development of advanced statistical techniques for accurate
data processing and interpretation. Our group has previously demonstrated that robust statistical methodologies
signiﬁcantly outperform the default ad hoc algorithms provided by technology developers. Our primary objective is
to address the most pressing challenges faced by the research community where our expertise can have the greatest
impact. The high citation rates of our statistical methodology and the widespread adoption of our open source
software highlight the success and impact of our work.
The applications of high-throughput technologies have evolved beyond their original purpose of DNA sequence
analysis to include dynamic and quantitative outcomes such as gene expression levels, with measurements now
available at the single-cell level. These advances introduce variability that further complicates data analysis,
particularly in distinguishing biologically relevant signals from unwanted noise. In addition, these measurements
are often subject to signiﬁcant technological and biological biases, which can profoundly aﬀect subsequent analyses.
Over the past ﬁve years, we have continued to develop solutions to tackle these types of challenges. The R35
mechanism has improved our productivity, broadened our research scope, and fostered new collaborations. Our
contributions in single-cell RNA sequencing have improved dimension reduction, cell annotation, and clustering.
Our ideas have established new standards and inﬂuenced the ﬁeld's direction. This work has been highly cited and
has served as the foundation for other statistically rigorous methods. We have also made signiﬁcant contributions
in spatial transcriptomics, developing the most widely used computational tool for cell-type annotation in this
technology, thereby establishing best practices in this rapidly expanding area. The ﬂexibility of the R35 mechanism
has also allowed us to extend our impact beyond genomics, as demonstrated by our contributions to public health
surveillance during the COVID-19 pandemic.
In the next ﬁve years, we plan to continue to address the most pressing challenges faced by investigators who rely
on high-throughput technologies. We will leverage the expertise of our collaborators to prioritize projects. Although
predicting speciﬁc future needs is challenging, we have identiﬁed key areas that we intend to address. Speciﬁcally,
we will develop methodologies and software to meet the most urgent needs of users of spatial transcriptomics
and scRNA-Seq technologies, create general approaches for inference in region-of-interest detection, and tackle
challenges identiﬁed through recently initiated collaborations. We will use the ﬂexibility of the R35 mechanism to
maximize the impact of our work and ensure that our eﬀorts continue to advance the ﬁeld.

Public health relevance
Project narrative Biomedical research is increasingly based on high-throughput technologies, which allow scientists to analyze thou- sands of molecular entities simultaneously, revealing new insights into diseases and genetic variations. During the past five years, our improved statistical methods developed under the R35 funding mechanism have greatly improved the way these complex data sets are interpreted, leading to more accurate scientific conclusions and innovative research directions. This work has not only impacted genomics research but has also expanded into other areas such as public health.